Task C07: The Development of a Cryopreservation Process for Arthropod Vectors of Human Pathogens

This contract provides for the development and standardization of difficult-to-source reagents that require the use of nontraditional animal models of infectious diseases.